Leveraging computationally derived measures of individual differences in learning and decision-making to predict psychiatric diagnosis, symptoms and changes in symptom severity across time

Leveraging computationally derived measures of individual differences in learning and
decision-making to predict psychiatric diagnosis, symptoms and changes
in symptom severity across time.
PI: John P. O’Doherty
PROJECT SUMMARY
The goal of computational psychiatry is to gain knowledge about underlying neurocomputational
processes that underpin psychiatric disorders and to leverage this knowledge for improving diagnosis
and treatment. A key step toward achieving this goal is to develop measures of individual differences in
computations obtained from a single individual that are reliable, robust and meaningfully relevant to
psychiatric dysfunction. In order to attain these objectives, it is essential we substantiate relationships
between candidate computational mechanisms and diagnostic categories, symptom dimensions and
treatment outcomes. In the present proposal, we utilize a computational assessment task battery (CAB),
designed to measure individual differences across a multidimensional array of computational processes.
We aim to separate three different variance components contributing to variability in computational
parameter estimation: occasion-related variance due to incidental day to day changes in task
performance, state-dependent variance that is related to meaningful variation across time in the
underlying computations within an individual, and trait-related differences pertaining to stable individual
differences in computations across individuals. To accomplish this, we will first implement repeated
assessments using this battery across a 1-year interval within an on-line sample, and use hierarchical
Bayesian modeling to separate the effect of occasion, state and trait-related variance on these
parameter estimates. We will then relate these variance components to diagnostic categories, symptom
dimensions and symptom severity measures in a diverse cohort of psychiatric patients (mostly with
depression, anxiety and OCD) recruited in Southern California. Finally, we will track the relationship
between the computational parameter estimates and changes in symptoms across time in a subset of
these patients. We hypothesize that overall diagnosis will be best predicted by trait variance
components, while current symptom severity will more closely relate to state-related variance in
parameter estimates. Our proposal promises to significantly advance understanding of how to reliably
extract diagnostically relevant computationally-derived measures of cognitive phenotypes that could
eventually be migrated to the clinic.

Public health relevance
NARRATIVE Our goal is to develop a comprehensive approach to characterize an individual’s ability to think, learn and make decisions in terms of a series of specific brain processes or ‘computations’. We then aim to determine whether variation in these computations relates to an individual’s susceptibility to different psychiatric disorders, and the symptoms they experience. To achieve this, we will develop new mathematical and experimental tools to identify different ways in which these computations can vary over time within and across individuals, and we will test how well we can predict an individual’s psychiatric status on the basis of these computational measurements.